MYC-alarmin axis as a novel therapeutic vulnerability in myelofibrosis

PROJECT SUMMARY
Myelofibrosis (MF) is a hematologic malignancy that is characterized by constitutional symptoms, splenomegaly,
bone marrow (BM) fibrosis, and high risk of transformation to acute myeloid leukemia (AML). MF is among the
most aggressive chronic myeloid neoplasms, with a median overall survival (OS) less than 4 years. Somatic
mutations in the JAK2, CALR, and MPL genes are common in ~85% of MF patients, and preclinical studies have
shown that these mutations result in constitutive activation of the JAK/STAT pathway, leading to chronic
inflammation and BM fibrosis. Accordingly, the FDA has approved three JAK2 inhibitors, Ruxolitinib, Fedratinib,
and Pacritinib, based on their clinical improvements in constitutional symptoms, splenomegaly and OS. However,
a substantial fraction of MF patients lack JAK2-activating mutations. Moreover, JAK2-activating mutations persist
in patients undergoing JAK2 inhibitor therapies and a subgroup of patients have suboptimal response to JAK2
inhibitors, underscoring the urgent need for developing new therapeutic strategies to improve clinical outcomes.
MYC is a transcription factor that controls cell proliferation, survival, and metabolism. Although MYC
plays important oncogenic roles in myeloid malignancies such as AML, its role in the MF pathogenesis is
unknown. Notably, our recent studies revealed that MYC copy number gain frequently occurs in MF patients and
that this is associated with increased levels of MYC protein expression in patient BM cells. Importantly, we have
shown that activation of MYC expression in mouse hematopoietic stem cells (HSCs) is sufficient to provoke MF
independent of JAK2, CALR, and MPL mutations, and that this requires upregulation of S100A9, an alarmin or
Danger Associated Molecular Patterns (DAMPs) protein that plays pivotal roles in inflammation and innate
immunity. Accordingly, the MYC-S100A9 axis underlies complex network of inflammatory signaling that involves
various hematopoietic cell types in the BM niche. Finally, we discovered that MYC also induces expansion of
mesenchymal stromal cells (MSCs) that are known as myofibroblasts contributing to the MF pathogenesis.
These findings support the hypotheses that activation of MYC-alarmin pathway drives MF independent
of JAK2/CALR/MPL mutations and that inhibiting MYC or its target alarmins will improve clinical outcomes in MF
patients having increased MYC expression. To test these hypotheses, we will assess the preclinical activity of
pharmacologic agents targeting the MYC-S100A9 axis in MF and determine the mechanisms of MYC-directed
upregulation of S100A9 (Aim 1). Further, we will assess the roles of MYC-S100A9 circuit in activation and
expansion of myofibroblasts and their contribution to MF development (Aim 2). Finally, we will define the roles
of MYC and its target alarmins in MF driven by JAK2 pathway mutations (Aim 3). Collectively, this research will
provide important insights into a new molecular circuit connecting MYC and alarmin-mediated inflammation, and
will test if the MYC-alarmin axis represents a novel therapeutic vulnerability that can be targeted to improve
clinical outcomes in MF.

Public health relevance
PROJECT NARRATIVE Despite advances in our understanding of the underlying genetic abnormalities in myelofibrosis (MF) and the development of JAK2 inhibitors, MF remains an aggressive chronic myeloid malignancy due to persistence of JAK2-activating mutations in patients undergoing JAK2 inhibitor therapy, the emergence of drug resistance, and a propensity for transformation to acute myeloid leukemia (AML). Thus, there is an urgent need to devise new treatment strategies that target the molecular and genetic aberrations driving MF development and clonal expansion, particularly in triple negative MF patients who lack mutations in the JAK2 kinase pathway. This R01 research program focuses on defining the roles of a new MYC-alarmin circuit that we have shown is sufficient to provoke MF, and to preclinically assess the therapeutic potential of targeting this pathway to improve outcomes in MF.